Utilizing Hybrid Antigen-Presenting Neutrophils to Prime WT1-Specific Immune Responses as Therapy for Acute Leukemia

PROJECT SUMMARY Although chemotherapy can induce remission in patients with acute leukemia, it is often
met with high probability of relapse. There is currently an unmet need for alternative therapeutic approaches
that effectively prevent relapse or that can be used to treat relapsed or refractory disease. Overwhelming
evidence suggests that the success of allogeneic hematopoietic stem cell transplantation to sustain complete
remission in leukemia patients relies on the presence of tumor-specific T cell immunity (graft-versus-leukemia
effect). Wilms tumor 1 (WT1) is overexpressed in nearly all pediatric and adult acute leukemias with evidence of
WT1-specific CD8+ T cells spontaneously arising in patients, highlighting its potential as a universal leukemia-
specific antigen. Our long-term goal is to develop an immunotherapeutic strategy incorporating full-length WT1
antigen to induce robust, anti-leukemic immunity in patients. The overall objective of this application is to
determine the utility of our Salmonella-based therapeutic, shIDO-ST, in eliciting WT1-specific immunity through
a unique population of antigen-presenting, polymorphonuclear neutrophils (APC-PMN). APC-PMN can be
generated in vitro by culturing of PMN with granulocyte macrophage-colony stimulating factor (GM-CSF) and
have been shown to prime T cell responses to foreign and cancer-associated antigens. Our central hypothesis
is that incorporating the WT1 transgene into shIDO-ST (WT1-shIDO-ST) will facilitate the coordinate generation
of hybrid APC-PMN presenting WT1 epitopes to induce effective anti-leukemic immunity. Our hypothesis has
been formulated on the basis of our own preliminary data confirming the ability of shIDO-ST treatment to
generate APC-PMNs in vivo that are capable of priming antigen-specific T cell responses. The rationale for the
proposed research is that a greater breadth of WT1-specific responses elicited by WT1-shIDO-ST therapy
represents a universal approach for treating leukemia patients. The central hypothesis and overall objective will
be tested by pursuing two specific aims: 1) Identify key features of WT1-specific immunity induced by WT1-
shIDO-ST therapy and 2) Determine the therapeutic efficacy of WT1-shIDO-ST treatment in leukemia models.
Targeting the most abundant leukocyte in the body to generate APC-PMN while also harnessing their antigen-
presenting functions are innovative aspects of our study. The proposed research is significant because it offers
a novel approach to elicit WT1-specific immunity and can be extended to incorporate antigens specific to other
malignancies or infectious diseases. Thus, this work will develop foundational resources that can be used by
researchers seeking to elicit antigen-specific responses in the prophylactic or therapeutic setting. The proximate
expected outcome of this work will be a greater understanding of the immune subsets contributing to WT1-
specific immunity, following WT1-shIDO-ST treatment, and their potential to eliminate leukemic cells. The results
of this study will have an important positive impact because they will establish a novel approach to elicit antigen-
specific responses, which in the long-term offers an alternative immunotherapeutic strategy for many diseases.

Public health relevance
PROJECT NARRATIVE Despite substantial improvements in survival rates for patients with acute leukemia, prognosis for patients with relapsed and refractory disease remains poor. The current proposal seeks to develop innovative bacterial-based strategies to induce anti-leukemic immune responses, which have the potential to be of both preventative and therapeutic value for patients who have relapsed or are at high-risk for relapse. The proposed research is relevant to public health because generation of long-term immunity to leukemia is expected to significantly extend patient survival.